Furthering scientific understanding of mechanisms underlying resilience to the effects of AD pathology by incorporating state of the art quantification of gliosis, inflammation, & synaptic toxicity

PROJECT SUMMARY The Adult Changes in Thought (ACT) study's second Specific Aim focuses on cognitive resilience; Aim 2c focuses on synaptic changes as a possible resilience mechanism. This Supplement evaluates related hypotheses regarding astrogliosis, inflammation, and synaptic toxicity by incorporating technological advances in Histelide (Histology and ELISA on a glass slide) that enable multiplexed assessment. The investigators will test the hypothesis that for a given level of amyloid beta (A?) and tau, astrogliosis (measured with GFAP), neuroinflammation (measured with Iba1), and synaptic degeneration (measured with synaptophysin) will be lower in people who are resilient to the neuropathological changes of Alzheimer's disease.

Public health relevance
PROJECT NARRATIVE This proposal is to add additional analyses of resilience, which is defined as the ability to avoid dementia during life despite extensive neuropathological findings at autopsy. Understanding the mechanisms of resilience is important as an additional means to potentially improve late life brain outcomes. Extensive state of the art assays are proposed to further characterize three additional processes in brains of a community-based cohort study with autopsy follow-up; the resulting data will be used to test hypotheses on the mechanisms of resilience.